Gene-edited liver organoids for predictive hepatotoxicity

Project Summary/Abstract
Unexpected adverse drug responses (ADRs) including drug-induced liver injury (DILI) are the 4th
leading cause of death in the U.S. In addition, DILI in individuals is one of the major reasons for drug
withdrawal from the market and is difficult to predict using conventional in vitro hepatotoxicity tests and
preclinical animal models. Due to the critical link between DILI and drug failure, there is an urgent need
for improved human hepatotoxicity testing in the early stage of drug development by investigating the
major pathogenic mechanisms of DILI, such as genetic variations in drug metabolizing enzymes (DMEs)
and drug transporters. To address this need, we propose to develop genetically engineered human liver
organoids (HLOs) on a pillar/perfusion plate using gene-edited, induced pluripotent stem cell (iPSC) lines
carrying CRISPR/Cas9 synergistic activation mediator (CRISPR-SAM), inducible Csy4, and multiplexed
guide RNA (gRNA), and recapitulate poor and ultrafast drug metabolizers in different ethnic groups. Using
normal and engineered HLOs on the pillar/perfusion plate, together with high-throughput, high-content,
HLO imaging assays, we propose to decipher the cellular and molecular mechanisms underlying the
toxicity of drug candidates and chemicals and assess DILI potential.
Our core hypotheses are: (i) overexpression of DMEs and drug transporters can recapitulate ultrafast
drug metabolizers in different ethnic groups that may be critical in addressing ADRs; (ii) metabolism-
induced hepatotoxicity can be established using normal and engineered HLOs with model compounds;
and (iii) high-throughput, high-content analysis of HLOs on the pillar/perfusion plate can be used to
identify DILI, which in turn can improve predictability of compound hepatotoxicity in vivo.
The specific aims of the proposed work are to: (1) create genetically engineered HLOs containing
doxycycline-inducible, CRISPR-SAM for overexpression of multiple hepatic genes to model ultrafast
metabolizers; (2) validate normal and engineered HLOs with model compounds, which undergo
metabolism and lead to toxic cellular responses in the human liver.
Although several human hepatic cell/tissue models including primary hepatocytes (ATCC),
engineered hepatoma cell lines (HepG2-CYP cell panel from Hera BioLabs), liver spheroids (3D InSight
liver microtissues from InSphero), bioprinted liver tissues (ExVive human liver tissues from Organovo),
and microfluidic liver chips (Liver-Chip from Emulate) are commercially available, these in vitro liver
models have been used for assessing general hepatotoxicity of compounds for normal drug metabolizers
and cannot easily simulate poor and ultrafast drug metabolizers in their assays who suffer the most from
DILI. Thus, there is great potential to apply engineered HLOs on the pillar/perfusion plate as a safety
assessment tool. Genetically engineered human organoids can be used to express any endogenous
proteins of interest in the cells for disease modeling by using a combination of guide RNAs. There is a
great potential for genetically engineered human organoids to be used to incorporate genetic diversity
into toxicity testing and for disease modeling.

Public health relevance
Project Narrative Bioprinting Laboratories Inc. proposes to leverage its unique “microarray three-dimensional (3D) bioprinting” technology and associated pillar/perfusion plates and generate normal and genetically engineered human liver organoids (HLOs) on the pillar/perfusion plates for recapitulating poor and ultrafast metabolizers in different ethnic groups due to allelic variations in drug metabolizing enzymes (DMEs) and testing vulnerability of drug-induced liver injury (DILI). Genetically engineered HLOs containing doxycycline-inducible, CRISPR/Cas9 synergistic activation mediator (CRISPR-SAM) will be used to overexpress multiple DME genes in different ethnic groups to simulate ultrafast metabolizers. Since current in vitro liver models are used mainly for assessing general hepatotoxicity of compounds and cannot easily accommodate genetic diversity in their assays, there is high commercial potential for normal and engineered HLOs.